Immune Response to RBC Antigens

ABSTRACT
Autoimmune hemolytic anemia (AIHA) causes significant morbidity and mortality; however, we still do not fully
understand how immune tolerance to red blood cells (RBCs) is established or broken. Given that RBCs are
required for life, are abundant, and have essential functions (e.g., tissue oxygenation), one would predict
stringent immune tolerance; however, tolerance failure occurs frequently. Indeed, 0.1% of healthy blood donors
and ~8% of hospitalized patients have detectable RBC autoantibodies. These autoantibodies can be clinically
significant, by inducing RBC clearance, hemolysis, antigen modulation, and increased risk for future AIHA or
cancer. Patients with AIHA present with pallor, fatigue, hemoglobinuria, splenomegaly, and/or life-threatening
hemolysis. Treatment strategies have variable success, with high relapse rates and mortality in ~11% of cases.
Supportive care using RBC transfusions is challenging as most autoantibodies recognize ubiquitous RBC
antigens; thus, virtually all donor units are crossmatch incompatible. The etiology of AIHA is generally unknown
and up to 50% of AIHA cases have no identifiable cause (“primary”). Secondary AIHA is frequently associated
with other autoimmune diseases and has been recently observed as a complication of checkpoint inhibitor
immunotherapies in the treatment of cancer. Thus, loss of tolerance to RBC autoantigens is an important medical
and scientific problem. To elucidate RBC tolerance mechanisms, we developed an innovative primary AIHA
murine model, which closely reflects human disease, a subset of mice develops age-onset hemolytic RBC
autoantibodies, anemia, splenomegaly, and reticulocytosis. Using this model, we pinpointed a 3-week
developmental timeframe during which RBC autoreactive recent thymic emigrants encounter RBC antigens and
become tolerized. Transcriptomic analysis identified novel pathways whose activity correlates with autoreactive
T cell tolerization, including 1) checkpoint molecules, 2) IL-10, and 3) purinergic signaling. Because AIHA is the
most frequently reported hematological adverse event due to cancer immunotherapy, we developed a novel
secondary AIHA model with checkpoint inhibitors. Loss of tolerance in the primary and secondary AIHA mouse
models is associated with an imbalance between regulatory T cells (Tregs) and proinflammatory TH17 T cells,
as well as a distinct population of CD39+ T cells. Herein, we leverage our preclinical AIHA mouse models to
determine which signaling molecules and/or pathways (i.e., checkpoint molecules, IL-10, or purinergic signaling
molecules) are required for T cell tolerance and AIHA prevention, and elucidate how biological factors, such as sex
and age, affect these requirements. The function of unique T cell populations (i.e., recent thymic emigrants, Treg
subsets, and CD39+ T cells) will also be defined. Understanding how the immune system responds to RBC
antigens will provide insight into not only autoimmunity to RBCs but may also have applicability to other
autoantigens present at high concentrations (e.g., platelet autoantigens, dsDNA) thereby making this a powerful
platform to study the requirements for tolerance to self-antigens in general.

Public health relevance
PROJECT NARRATIVE Non-responsiveness (i.e., tolerance) to one’s own tissues is essential to prevent autoimmune disease. In some individuals, tolerance breaks down and the immune system destroys one’s own red blood cells; this can be fatal as these cells are required for life. This proposal will identify which pathways and T cell subsets are required for tolerance to one’s own red blood cells, and define how age and sex modify those requirements.